Cellular rejuvenation during oogenesis

Dysfunction of the nuclear pore complex (NPC) has been extensively linked to aging and neurodegenerative
conditions such as ALS and Alzheimer’s disease. NPCs are large nuclear envelope-embedded protein
complexes composed of about 30 Nucleoporin (Nups) that regulate nucleocytoplasmic exchange as well as
genome function. Many Nups exhibit unusually slow turnover and thus accumulate damage with age, which is
thought to contribute to age-associated NPC dysfunction and loss of cellular fitness. Recent studies revealed
that defective NPCs and acute stress induce NPC recycling via autophagy in yeast, but whether this mechanism
occurs in metazoans and its physiological relevance are unknown. Damaged cellular machinery can lead to
organismal dysfunction and aging, yet irrespective of the age of the parents, the gametes, such as oocyte and
sperm, ensure that the next generation starts afresh with undamaged components. Our labs investigate the
mechanisms underlying the differentiation of germline stem cells (GSCs) into oocytes, the only cells of the female
that contribute to the next generation and defy aging, and physiological roles of the NPC. Autophagy appears to
be active during GSC differentiation in Drosophila, but the biological significance is not completely understood.
We recently described pathways required for a germ cell-to-maternal transition during Drosophila oogenesis that
is required for oocyte specification and maintenance. We demonstrated that early oogenesis genes are silenced
during this transition via a mechanism involving heterochromatin and NPCs, and that heterochromatin formation
during mid-oogenesis triggers upregulation of most Nups. Our preliminary results suggest that NPCs undergo
extensive removal during this critical window of oogenesis, which overlaps with transcriptional induction of Nups.
Additionally, we found that an autophagy factor Atg8 can be targeted to NPCs during germ cell-to-maternal
transition and that loss of Atg8 leads to germ cell abnormalities and aberrant expression of early oogenesis
genes. Thus, our central hypothesis is that selective autophagy and programmed transcription underlie an
“NPC rejuvenation” program during oocyte specification to ensure oocyte viability and progeny fitness. We plan
to address this hypothesis with the following three specific aims: 1) Define the spatiotemporal dynamics of NPC
turnover during the germ cell-to-maternal transition; 2) Determine the factors that promote NPC rejuvenation
during the germ cell-to-maternal transition; and 3) Determine the biological relevance of NPC rejuvenation
pathways to oogenesis and fertility. We expect to discover that the germ cell-to-maternal transition resets cellular
lifespan in part by driving a developmentally regulated NPC rejuvenation program, involving coordinated
clearance of old NPCs by autophagy and the synthesis of new NPCs via heterochromatin formation-dependent
transcription. We anticipate our research will uncover new concepts in developmental biology, regenerative
medicine, and aging.

Public health relevance
Project Narrative Irrespective of the age of the parents, the gametes ensure that the next generation starts afresh with undamaged cellular components but how this is accomplished is not fully understood. Using Drosophila female germline as a model, we have determined that nuclear pore complexes (NPCs) are degraded, likely via autophagy, prior to synthesis of new NPCs as the oocyte is specified, suggesting a rejuvenation program for NPCs. Understanding how old cellular components such as NPCs are removed during oogenesis will give us tools to reverse aging and design regenerative therapies.